Genetically testing mechanisms of ocular development and disease

PROJECT SUMMARY AND RELEVANCE
Ocular anterior segment dysgenesis (ASD) is a genetically heterogeneous group of developmental disorders
affecting the front of the eye. Individuals with ASD have a greatly elevated risk of developing severe and early
onset glaucoma that is refractory to treatment. Between 50-75% of patients with ASD develop glaucoma, which
occurs at significantly younger ages than in the general population, leading to disproportionately diminished
quality of life for these individuals and their families. Despite decades of study, the cellular and molecular details
of normal ocular development are still poorly understood, and disease mechanism remain elusive.
Mutations in the genes encoding collagen IV alpha 1 (COL4A1) and alpha 2 (COL4A2) cause a multisystem
disorder that includes ASD and glaucoma. Importantly, we recently discovered that Col4a1 mutant mice have
elevated TGFb signaling and that reducing TGFb signaling partially rescued ASD. We hypothesize that Col4a1
mutation and elevated TGFb signaling affect differentiation of the periocular mesenchyme (POM) – a transient
embryonic tissue derived from neural crest cells and paraxial mesoderm. The POM gives rise to structures of
the ocular anterior segment including corneal endothelium and stroma, iris stroma, trabecular meshwork, and
ciliary muscle. Despite its importance, the small size and transitory nature of the POM has made it difficult to
study. This project will apply recent advances in single cell and spatial transcriptomics to overcome this obstacle
and enable unprecedented investigation of the cellular and molecular mechanisms of anterior segment
development and dysgenesis.
The proposed project uses both unbiased and hypothesis driven approaches to answer central questions about
where, when, and how pathogenesis arises, reveal other potential disease mechanism, and understand how
molecular mechanism(s) might converge with other known genetic causes of ASD in humans. The successful
completion of this project will provide foundational knowledge of normal ocular development and novel insights
into molecular mechanisms underlying ASD and developmental glaucoma.

Public health relevance
PROJECT NARRATIVE Individuals with developmental abnormalities of structures in the front of the eye are at high risk to suffer from early onset glaucoma that is refractory to treatment. We will use state-of-the-art approaches and innovative resources to perform foundational studies for that will yield novel understanding of mammalian ocular development. Understanding pathogenic mechanisms will be informative for disease prognosis and treatment, and awareness of potentially life-threatening comorbidities.